A Controlled Septal Ablation for Inoperable Hypertrophic Cardiomyopathy

Project Summary
Hypertrophic cardiomyopathy (HCM) is a genetic disease that results in abnormal thickening of ventricular heart
muscle, particularly the septum, causing left ventricular outflow tract (LVOT) obstruction. When medication alone
is not sufficient to relieve symptoms, the current gold standard, septal myectomy, is performed to surgically
remove excess muscle with an open heart surgery. Unfortunately, many patients are poor surgical candidates
and require less invasive treatment options. In these cases, cardiologists treat the patients with a minimally
invasive catheterization technique called alcohol septal ablation (ASA), in which 1-4 mL of pure alcohol is injected
into the septum via a septal perforator (artery) to destroy part of the septal muscle by triggering necrosis.
However, the diffusive nature of pure alcohol causes dangerous uncontrollable necrosis and a very high
complication profile for a minimally invasive technique. Risky complications of ASA, with a periprocedural
mortality rate of ~2%, include atrioventricular block, ventricular fibrillation/tachycardia, and complete heart block
due to lack of control of alcohol localization and indiscriminate tissue destruction. To answer the unmet clinical
need, recently cyanoacrylate (super glue) was investigated as a replacement for pure alcohol but experienced
challenges in efficacy and long-term safety. To overcome those limitations, our goal is to design a novel ablation
system to replace the pure alcohol in ASA and achieve a controllable, localized septal tissue shrinkage and
hence a safer ablation. Based on our preliminary data, we hypothesize that the delivery of a collagenase-coated,
doxorubicin-loaded, degradable nanoparticles (NPs) will allow for localized doxorubicin-induced destruction of
the hypertrophic cardiomyocytes, and this single dosage delivery will lead to regression of the overgrown HCM
septal tissue. Doxorubicin was recently found to be responsible for the clearance of unwanted hypertrophic
cardiac tissue, and the proposed single dosage delivery can avoid cardiac toxicity often caused by repeat
exposure. Three aims will thus be pursued to better understand HCM septal tissue and develop this novel
treatment approach: (1) Determine the biomechanical and microstructural abnormalities of human HCM septal
tissues and develop a biomimicking in vitro 3D HCM model; (2) Develop a collagenase-coated, doxorubicin-
loaded, biodegradable nanoparticle ablation system and optimize the ablation system using the in vitro 3D HCM
model; (3) Validate the safety and efficacy of the newly developed ablation system in an HCM mouse model.
The proposed research paves a new avenue to improve the safety and efficacy of septal ablation in inoperable
HCM patients. The impacts are (i) the innovative concept and design of a controllable, localized ablation to
replace the unpredictable, diffusive pure alcohol ablation, and (ii) the promising translational potential. This AREA
project will also provide valuable NIH-funded research opportunities to our underrepresented undergraduate
students at UT Arlington, a Hispanic-Serving Institute in Northern Texas.

Public health relevance
Project Narrative Alcohol septal ablation (ASA) is a minimally invasive catheterization technique to destroy part of the obstructive septal muscle for patients with inoperable hypertrophic cardiomyopathy by injecting pure alcohol to trigger tissue necrosis. The diffusive nature of pure alcohol causes dangerous uncontrollable necrosis and a very high complication profile for a minimally invasive technique, suggesting a more localized, controllable ablation is needed. The main objective of this proposal is thus to design a novel ablation system to replace the pure alcohol in ASA, and hence achieve a controllable, localized septal tissue shrinkage and safer ablation.